Development of Stem Cell-based Therapies for Limbal Stem Cell Deficiency

Project Summary
Limbal stem cell deficiency (LSCD), a blinding corneal disease, is caused by damage to the limbal stem cells or
their niche microenvironment. The clinical presentation of LSCD varies greatly based on the severity of the
condition, determined by the quantity of functional limbal stem cells (LSCs) remaining in the eye. Therefore,
accurately diagnosing and staging LSCD through clinical examination alone is challenging and subjective. The
lack of standardized diagnostic methods and disease severity staging has hindered therapy advancements, as
uniform criteria are needed to establish standardized outcome measures for comparing the efficacy of different
treatments. Moreover, treating LSCD should be tailored according to the severity and laterality of the disease.
Transplanting cultivated LSCs may be a safer approach than limbal tissue grafting for severe to total LSCD, as
it requires less donor tissue. However, no medical treatment exists for partial LSCD, and standardized quality
controls and potency assays are lacking, preventing the quantification of stem cell content without sacrificing
the cultivated stem cells for transplantation. Addressing these unmet medical needs, during our last funded
period, we characterized several in vivo parameters of LSCD using a non-invasive diagnostic protocol
employing multimodal in vivo imaging. This protocol has shown higher accuracy in diagnosing and staging the
disease than clinical examination alone Additionally, we developed a robust xenobiotic- and feeder-free LSC
manufacturing process and a new LSC therapy, currently under investigation in a Phase I clinical trial. Building
upon this progress, the current proposal aims to develop a "liquid biopsy" of the conditioned media of cultivated
LSCs for quality control and stem cell content quantification. This will be complemented by a deep machine
learning approach to evaluate cultured cell morphology. In parallel, we will identify prognostic biomarkers of in
vivo LSC function from serial in vivo multimodal images. Furthermore, to comprehend the ocular surface
microenvironment and develop tear biomarker(s) for LSCD, differential profiling of tear components in eyes
with LSCD, normal eyes and eyes with comorbidities in LSCD will be investigated using a multi-omic
approach.

Public health relevance
Project Narrative Damages to the limbal stem cell or their niche microenvironment could lead to limbal stem cell deficiency (LSCD), a potentially blinding disease. The proposed studies aim to establish secreted biomarkers of cultivated LSCs and tears using molecular techniques (liquid biopsy). In parallel, in vivo biomarkers of LSCD from multimodal imaging using deep learning will be carried out, which will greatly raise the standard of care for LSCD.